Spatial genomics and cell atlas of the human brain

Project Summary
The human brain is composed of an exceptionally high diversity of cells and brain function is orchestrated by
complex interactions of these different types of cells. The enormous cellular diversity and complex
organization of the brain have so far hindered our understanding of the molecular and cellular mechanisms
underlying brain function. To date, it is still unclear how many different types of cells are present in the human
brain and how they are organized. We have previously developed a spatially resolved single-cell genomics
method, Multiplexed Error Robust Fluorescent In Situ Hybridization (MERFISH), which allows in situ gene-
expression profiling of individual cells and hence in situ identification and spatial mapping of transcriptionally
distinct cell types in complex tissue, including the brain. However, the technical limitations of MERFISH still
prohibit a comprehensive spatial analysis of cell types and states across the entire human brain. In this
project, we will extend MERFISH to enable higher imaging speed/throughput, 3D volumetric imaging, and
epigenomic-transcriptomic multimodal imaging, and we will use these approaches to identify cell types and
cell states, map their spatial organization, and predict cell-type-specific cell-cell interactions in the human
brain, including the aging brain. In Aim 1, we will develop methods to drastically increase MERFISH imaging
speed/throughput (by 10-fold or more) and to enable 3D volumetric MERFISH imaging of thick tissue samples,
which will further increase the imaging throughput and greatly improve our ability to capture and map cell-cell
interactions. We will also extend MERFISH to allow spatially resolved single-cell profiling of not only histone
modifications but also DNA modifications, and combine transcriptomic and epigenomic MERFISH to enable
spatial multi-omics. In Aim 2, we will use the above-described approaches to generate spatially resolved cell
atlases and cell-cell interaction maps of several human brain regions, including several cortical regions
(prefrontal cortex, primary motor cortex, primary visual cortex, and middle temporal gyrus), several regions in
the basal ganglia (caudoputamen, globus pallidus, substantia nigra, and subthalamic nucleus), and the
preoptic region of the hypothalamus. In Aim 3, we will use the MERFISH technology, including the newly
developed capabilities described above, to study the human prefrontal cortex from donors of different ages,
including advanced ages, to characterize how the composition, cell state, spatial organization, and cell-cell
interactions of molecularly defined cell types in the prefrontal cortex change during aging. Our proposed
studies will provide fundamental insights into the molecular and cellular architecture of the human brain and
how it changes during aging.

Public health relevance
Project Narrative In this project, we propose to develop and apply spatially resolved single-cell transcriptomics and epigenomics methods to classify cell types and states, map their spatial organization, and determine cell-type-specific cell- cell interactions in the human brain. Our results will provide fundamental insights into the structure and function of the human brain at the molecular and cellular level. The technological innovations and scientific results obtained from this project can also be applied to understand brain diseases and aging.